Alzheimer's Clinical Trials Consortium (ACTC)

SUMMARY. This is a multi-PI application for the U24 Cooperative Agreement to develop a state-of-the-art
Alzheimer Clinical Trial Consortium (ACTC) to support the conduct of academic clinical trials across the
continuum of Alzheimer's disease (AD). This ACTC will leverage the depth and breadth of AD clinical research
teams at USC, Harvard, and the Mayo Clinic, as well as the considerable experience of investigators at 35
expert AD trial sites. We aim to create an optimized infrastructure to more efficiently launch, rapidly recruit,
improve the diversity, and successfully complete NIH supported clinical trials in AD and related dementias. We
will utilize streamlined contracting processes, a centralized IRB with a specific focus on neurodegenerative
diseases, and incorporate state-of-the-art informatics and statistical analyses. We propose to redouble our
efforts to improve the diversity of participants in AD clinical trials, incorporating learnings from our recent
experience, and establishing a new Minority Outreach and Recruitment (MORE) Team to support both central
and local partnerships with communities of color. We will foster continued innovation in AD trial design,
providing expertise on novel cognitive, imaging, and biomarker outcomes to support future ACTC trial
applications. We will evaluate promising exploratory measures imbedded in our current trials, such as Tau
PET imaging and computerized cognitive testing, and work to incorporate these measures into a robust
platform for future Proof of Concept (POC) trials to rapidly assess signals of efficacy. We propose a tightly
coordinated, distributed leadership model to create a true consortium and take full advantage of the expertise
across multiple institutions. The ACTC Coordinating Center will leverage the highly experienced teams in
Clinical Operations, Data Systems and Management, and Biostatistics at USC. The MRI Unit, led by Mayo,
and PET Unit, led by Harvard and UC Berkeley, will capitalize on unparalleled experience with multi-site
protocols through ADNI, the A4 Study, and multiple ongoing clinical trials. The Clinical Outcome Instrument
and Biomarkers Units will leverage world-class expertise from Mayo, Harvard, and USC to incorporate both
standard and novel outcome measures in future trial designs. This ACTC will provide expertise and
infrastructure to design and conduct trials across the full continuum of AD, from primary prevention initiatives to
combination trials for advanced symptomatic stages. We also stand ready to collaborate on trials in other age-
related dementias, leveraging the experience of the NeuroNext team at Harvard and other expert investigators
in vascular and non-AD neurodegenerative diseases. We will build on our successes with public/private
partnerships and continue to strengthen our strategic alliances to conduct large scale trials, but will also focus
on supporting novel approaches to smaller investigator-initiated POC studies that will better inform Phase 3
decision-making. Finally, we will provide training and leadership opportunities to young clinical investigators to
facilitate continued innovation in trial design, and catalyze the next generation of AD clinical trials.

Public health relevance
Narrative Alzheimer's disease (AD) remains one of greatest unmet medical needs in our country with estimates of over 5 million Americans suffering from the disease in 2016 with no new symptomatic therapies having been approved over the past 12 years, and currently no approved disease-modifying agents. The timeframe, complexity, and expense of the recruitment process and site activation for AD trials are extremely challenging, and indeed trial enrollment and site network development represent a bottleneck for drug development for the AD field; there is a growing consensus that we must fundamentally overhaul the current clinical trial recruitment and assessment structure. This proposal aims aim to create an optimized infrastructure to optimally design, efficiently launch, rapidly recruit with improved diversity, and successfully complete NIH supported clinical trials in AD and related dementias.